Building Reliable Vision-Language Assistant for Dermatology AI through Modeling Uncertainties in Multimodal LLMs

PROJECT SUMMARY
Diagnosis delay is one of the key factors that lead to skin cancer death, especially for melanoma diagnosis during
the COVID-19 pandemic. The long examination time and limited dermatological access have been the major
roadblocks to the preventive treatment of skin cancers to lower the high mortality rate. Developing a clinical AI
agent that can analyze digital skin images and provide timely, interactive text responses to patient symptoms and
inquiries will signiﬁcantly mitigate the nationwide dermatologist shortage, thereby improving the early diagnosis
chance and teledermatology accessibility for melanoma as well as other skin diseases. Conventional dermatology
AI methods mainly focus on medical image recognition to identify skin lesions and malignancies, falling short in
visual-language assistance for remote healthcare services. A conversational diagnostic AI model, which is able
to answer medical questions by sensing subtle visual patterns of skin disorders/cancers, is still in urgent need.
The long-term goal of this research program is to develop a reliable large visual-language (VL) model that enables
conversational Dermatology AI to facilitate early melanoma diagnosis and general skin care. The proposed
research will generate accurate and interpretable clinical responses by ﬁnetuning Large Language Models –
LLMs (e.g., the generative AI models deployed in ChatGPT) through answering questions and visual reasoning
in multimodal contexts. Speciﬁcally, the project will realize three aims: 1) Build a new multimodal LLM speciﬁcally
for dermatology to discern melanoma and other skin diseases and to automatically answer questions relevant to
skin lesions. 2) Study uncertainties stemming from data bias and distribution shifts to enhance the reliability of
LLM-powered AI diagnosis in multimodal contexts and teledermatology environments. 3) Determine the visual
relevance in LLM decisions based on the rich public dermatological images with clinical text annotations.
The proposed research will establish a new multimodal LLM that interweaves visual reasoning and uncertainties
to advance Dermatology AI in broad VL assistance tasks, enabling automatic conversational diagnostic in teled-
ermatology and providing new insights about how LLM understands skin lesions and dermatological knowledge.
A pixelwise visual instruction tuning approach and a novel multi-level uncertainty quantiﬁcation framework will be
developed, providing technical foundations to beneﬁt a wide range of LLM-based healthcare research.
This project will be the ﬁrst large visual-language research study that investigates LLM's intelligence and reliability
in coping with multimodal dermatology contexts – visual skin lesions and text clinical annotations/dialogues.
The success of this project will provide transformative AI techniques in assisting early melanoma diagnosis and
remote skin care, leading to better teledermatology accessibility for patient treatments, reducing mortality from
skin cancers through timely detection, and revolutionizing dermatological access in public healthcare systems.

Public health relevance
NARRATIVE Teledermatology aided by conversational AI can signiﬁcantly reduce skin cancer death by highly improving the early diagnosis rate of melanoma. The proposed research will determine the dermatological knowledge learned by large language models – LLMs (e.g., ChatGPT/GPT-4V) on critical visual clues of skin malignancies through visual reasoning and uncertainty quantiﬁcation. The LLM knowledge and novel techniques gained from this project are of high signiﬁcance in realizing automatic conversational AI diagnostic for teledermatology, thereby mitigating the national dermatologist shortage and making skin care more accessible to underserved populations.